Multiplexing Protein Analysis Core

The goal of the Multiplexing Protein Analysis Core (MPAC) is to provide users with specialized tools to
determine the dynamic regulation of the proteome. As in the previous cycle, our primary service includes the
rigorous, sensitive and precise quantification of panels of proteins relevant to the basic biology of aging and
age-related disease. For this cycle, we expand the capabilities of the core by adding stable isotope tracer
experiments with deuterium oxide (D2O) to measure the turnover of proteins. Although core facilities that offer
discovery-based proteomics are relatively common, only a few cores offer these targeted methods. Further, the
Core offers these assays in panels that interrogate specific biochemical pathways important in aging and can
design new assays and panels on request for any protein from any animal with a sequenced genome. In
addition, the Core can use its targeted approaches for post-translational modifications such as
phosphorylation. There are also relatively few laboratories with the expertise to measure protein turnover rates
using stable isotopes. Measuring synthetic rates with tracers requires proper study design, mass spectrometry
with appropriate sample preparation and analysis, and correct interpretation of data. The advantages of D2O
for Core users are significant. Specifically, it is cheap, highly sensitive, flexible, biologically inert, lends itself to
long-term labeling, and can be used to measure the synthesis of a variety of molecules. The combination of
D2O labeling and targeted proteomics in one sample allows users to understand changes in the content of
individual proteins, the turnover processes that drive the changes, and mechanisms such as cell proliferation
and ribosomal biogenesis that contribute to these changes. Finally, the analyses provided by the core are
made on frozen samples, facilitating ease of sample collection for outside users. The Core proposes two
specific aims: 1) Develop and apply high throughput multiplexed protein quantification for panels of proteins,
including post-translational modifications, in experimental systems used by Geroscience investigators,
including mice, rats, fruit flies, C.elegans, and yeast, and 2) Use stable isotope labeling and analysis in
combination with multiplexed protein quantification to measure turnover of individual proteins as well as
processes that contribute to the regulation of protein abundance. To accomplish the aims, the MPA Core uses
selected reaction monitoring (SRM) and parallel reaction monitoring (PRM) in tandem mass spectrometry
systems or high-resolution accurate mass (HRAM) selected ion monitoring (SIM) in an orbitrap mass
spectrometry system, as well as GC-MS based analysis of supportive measurements. The ability to adapt
these procedures to multiple cell types, tissues, and model organisms make the MPA Core a significant
resource for the aging research community.